THE REGULATION OF NEUTROPHIL EXTRACELLULAR TRAPS (NETS) BY ADENOSINE IN MYOCARDIAL ISCHEMIA-REPERFUSION

PROJECT SUMMARY/ABSTRACT
Reperfusion of the ischemic heart is lifesaving in myocardial infarction, but the physiologic processes
triggered by reperfusion can cause subsequent damage. The innate immune system plays a prominent role in
reperfusion injury. Neutrophils release multiple toxic mediators and the appreciation of the role of neutrophil
extracellular traps (NETs) in MI/R pathophysiology is gaining importance. Adenosine is known to mitigate many
pro-inflammatory immune processes while ATP released from dying and necrotic cells, activates immune cells.
ATP is metabolized to adenosine by ectonucleotidases expressed on many cells including mesenchymal
stromal cells (MSCs). MSCs are known to highly express ecto-nucleoside triphosphate diphosphohydrolase-1
(NTDPase1, CD39) and ecto-5’-nucleotidase (CD73). Modulation of purinergic metabolism may be a powerful
mechanism used by MSCs to inhibit inflammation in their native bone marrow as well as when transplanted for
therapeutic purpose.
Currently little is known about endogenous regulation of NET production and we have hypothesize that
adenosine may be a key endogenous regulator. Our preliminary data shows that MSC transplanted to the
heart encapsulated in alginate can modulate the innate inflammatory response to MI/R. Furthermore,
encapsulated MSCs increase myocardial adenosine levels, reduce reactive oxygen species, and decrease the
number of leukocytes and neutrophils in the heart after 24 hours. We will use human neutrophils as well as
neutrophils isolated from mice lacking key adenosine receptors to understand the role of adenosine signaling
in MI/R. We will also use a rodent model of MI/R to test our novel NET-regulatory strategy in vivo. The results
of these studies will identify new therapeutic strategies for treatment of innate immune MI/R injury.
It is our aims to 1) delineate the importance of adenosine receptor 2A (A2A) signaling in the regulation of
NET formation; 2) evaluate the intracellular signaling pathways involved in NET regulation; 3) test the feasibility
of MSC modulation of purinergic metabolism to prevent NETs in MI/R.

Public health relevance
PROJECT NARRATIVE Cardiac ischemia-reperfusion injury is a significant cause of morbidity, mortality, and cost. Neutrophil extracellular traps (NETs) released by neutrophils in the reperfused myocardium may greatly contribute to inflammation, thrombosis, and myocardial damage during reperfusion but nothing is known about the regulation of NETs. We have hypothesized and will test the premise that adenosine may be an endogenous regulator of NETs and that mesenchymal stromal cells, through metabolism of ATP to adenosine, can reduce NET production.